Therapeutic Implications of Molecular Defects in Bone Marrow Failure

ABSTRACT
Bone marrow failure syndromes (BMFS) include myelodysplastic syndrome (MDS), aplastic anemia (AA) and
paroxysmal nocturnal hemoglobiuria (PNH) and are diseases characterized by failed blood production, stem
cell failure and various degrees of clonality marked by the presence of somatic genomic lesions. These
conditions have not only a growing socioeconomic and medical importance, but also their basic study has
provided ground-breaking discoveries with implications for the understanding the physiologic pathophysiologic
mechanisms within hematopoiesis and beyond for the whole field of hematology. The main focus of my early
scientific career as physician scientist and hematologist has been on study immune pathogenesis, ways of
stem cell enumeration, mechanisms of stem cell damage and molecular genetics of BMFS. The latter themes
initially included discovery of new somatic and germ line lesions and subsequently transitioned to mechanistic
studies. These lines of investigations, specifically pertinent in this R35, yielded important clues as to the
mutational spectrum in MDS and later led to the growing appreciation of the role of clonal hierarchy and
dynamics not only in MDS, but also in AA and PNH. Our team has made significant contribution to these
advances made possible by a continuous funding from NHLBI and other sources. Our experience, commitment
to the field, and created infrastructure provide a solid base for proposed expansions of ongoing molecular
studies towards new paradigm-shifting scientific goals. By taking advantage of the newest molecular
discoveries of somatic and germ line mutations and through progress in clarifying their mechanistic
consequences, we believe that it is now time to advance translational goals to make tangible advances in
medical care including diagnostics and therapeutics for BMFS. Such investigations would also contribute to
improved understanding of basic disease mechanisms mediated by selected subset of common and important
somatic mutations. We will use the newest technologies, including single cell sorting and sequencing, to further
study the clonal architecture to identify targetable early events and also determine the dependence of clonal
cells on these events following acquisition of subclonal lesions. These genomic investigations will involve also
germ line lesions and their contribution of late manifestation of adult BMFs. They will provide substrates for
mechanistic studies aiming at development of conceptually new therapeutic strategies. This theme will initially
involve TET2 and other dioxygenases, DNMT3A and other histone and DNA methylases and spliceosomal
mutations. These studies will also define the impact of germ line alteration and using integrative approaches
identify disease subgroups by the presence of convergent pathways and results will provide a canvas for the
rational selection of most suitable targets for development of new treatment strategies.

Public health relevance
PROJECT NARRATIVE Bone marrow failure syndromes (BMFS) include myelodysplastic syndrome (MDS), aplastic anemia (AA) and paroxysmal nocturnal hemoglobiuria (PNH). The main focus of my scientific career as physician scientist and hematologist has been on study immune pathogenesis and mechanisms of stem cell damage and molecular genetics of these diseases. Our team has made significant contribution to these advances made possible by a continuous funding from NHLBI and other sources. Our experience, commitment to the field and created infrastructure provide a solid base for proposed expansions of these studies towards new paradigm-shifting scientific goals and the development of new treatment strategies.